Advancing Capacity to Integrate Exercise into the Care of Older Cancer Survivors: The ACES initiative to establish guidelines, feasibility and best practices for research in cancer and aging

The growing number of aging cancer survivors will pose a significant challenge for the healthcare system
because of the combined effects of cancer treatment and aging on the development of comorbid disease,
disability, and accidental death from injuries such as falls. Withinjust 5 years the number of older survivors in
theUnited States alone is projected to reach 14 million.Exercise has the potential to improve functioning and
QoL in older adults with cancer, however, and despite recent
American
to
survivors.
Research
because
exercise guidelines for cancer survivors from an
College of Sports Medicine (ACSM) and the American Society of Clinical Oncology (ASCO) but, due
the lack of clinical trials in older cancer survivors, neither position issued age-specific guidelines for older
Thus, clinical practice remains bereft of guidance to include exercise in care plans for older patients.
in older adults with complex health needs is challenging and they are often excluded from clinical trials
teams lack the expertise, experience and resources.An NIH funded cancer, exercise and aging expert
group they noted an absence of rigorously planned phase I-II feasibility trials for different exercise modalities
that would subsequently inform the a priori design of phase III efficacy trials. Despite this urgent call, there have
been no rigorously designed phase I studies in older cancer survivors, including those with functional limitations,
to establish the feasibility and safety of any exercise modality and particularly, resistance training. The
exercise
research
improve
lack of
guidelines and the paucity of clinical t rials specific t o older cancer survivors creates a significant
gap that i s impeding the implementation of exercise as a low-cost, accessible, and scalable strategy to
outcomes for older survivors.We are directly responding to NOT-CA-22-030 stating NCI's participation
in PA-20-070 Research Infrastructure Development for Interdisciplinary Aging Studies that calls for phased
R21/R33 applications for “studies that propose
advance
developing or scaling up a novel research infrastructure that will
the science of cancer and aging requiring interdisciplinary collaborations”. Per the PA-20-070 guidelines
requiring milestone-driven projects, we propose the following phased R21 to R33 projects: R21 project:
Develop consensus-based guidelines for exercise in older (65+) cancer survivors by: 1) assembling a community
advisory board for stakeholder input (Y1); 2) conducting a review of published trials and trials in progress (Y1),
3) conducting a Delphi study to outline an initial set of exercise recommendations (Y1); 4) convening an
interdisciplinary working group of experts to develop consensus-based exercise guidelines for older cancer
survivors (Y2); and, 5) finalizing a guideline-concordant R33 project protocol (Y2). R33 project: Establish the
feasibility and safety of resistance training in older functionally limited cancer survivors by: 1) conducting a phase
I trial that is concordant with guidelines from the R21 (Y3-5), 2) establishing appropriate comparison groups for
futures studies of functional outcomes in older cancer survivors (Y5) and 3) producing a set of best practice
guidelines for the conduct of clinical exercise trials in older adults (Y5).

Public health relevance
Our R21/R33 phased innovation proposal aims to build capacity that will fill critical research and practice gaps in cancer, exercise and aging. Our R21 project will develop consensus-based guidelines for exercise in older (65+) cancer survivors that will, in turn, inform the protocol and practices for our R33 project that will establish the feasibility and safety of resistance training in older, functionally limited cancer survivors – a rapidly growing demographic of the cancer survivor population in which we have little specific guidance for using lifestyle-based approaches to preserve their functioning and quality of life.